ERK-mediated regulation of RNA binding protein condensation during female germ cell development

Project Summary
A fundamental gap exists in understanding the mechanisms that maintain the maternal mRNAs
necessary for oocyte growth and early embryogenesis. Birth defects and infertility can arise if mRNAs are not
properly regulated. Many mRNAs and RNA binding proteins undergo regulated phase separation that can
result in granules. In the human ovary, infertility is associated with ectopic granules of RNA binding proteins.
Despite their critical nature, the molecular mechanisms that regulate phase separations of oogenic RNA
binding proteins are not yet well understood. The long-term goal is to identify mechanisms that allow oocytes to
maintain their quality throughout oogenesis. The primary objective of this application is to identify the ERK
(extracellular signal regulated kinase)-mediated mechanisms that modulate RNA binding protein phase
transitions and function in oogenesis. The two central hypotheses are: 1) the canonical Ras-ERK signaling
pathway acts in oocytes to inhibit the condensation of RNA binding proteins into RNP granules which is
necessary for the translational regulation of mRNAs, and 2) ERK modulates condensation via regulation of the
CCT chaperonin and/or remodeling of the ER or cytoskeleton. These hypotheses have been formulated based
on results in the PI’s lab showing depletion of ERK activity results in ectopic granules of two RNA binding
proteins, and cellular remodeling is associated with RNP granules. The overall approach is to investigate the
condensation of RNA binding proteins using an outstanding in vivo model of oogenesis in the nematode C.
elegans. The approach is educationally innovative because it involves a large number of undergraduates,
some of whom will be involved in authentic research in an elective lab course. The strategy also integrates a
powerful combination of genetics, cell biology, and microscopy. The first aim is to elucidate the role of the
canonical Ras-ERK signaling pathway in regulating RNA binding protein condensation. The role of the G
protein signaling pathway in the sheath cells will also be determined, as well as the effect of depleted ERK
activity on the translational regulation of maternal mRNAs. The second aim is to characterize the composition
and dynamics of ectopic RNP condensates and identify candidate ERK substrates that mediate the inhibition of
condensation. The effects of depleting ERK activity on diverse classes of RNA binding proteins and mRNA will
be determined. A combination of genetics and transmission electron microscopy will be used to determine if
ERK regulates remodeling of the ER and cytoskeleton. These results will be used to screen candidate ERK
substrates to identify downstream ERK targets. Overall, this contribution will provide an understanding of the
regulation of RNA binding proteins and maternal mRNAs that may have critical importance in maintaining
gamete quality. This project is significant as it will uniquely contribute to the field by uncovering upstream ERK
pathways that regulate the phase transitions of RNA binding proteins in oogenesis. Candidate ERK substrates
will provide targets for future biochemical studies and to modulate the pathway for interventions.

Public health relevance
Project Narrative The proposed project is relevant to human health because when the condensation of RNA binding proteins is not properly regulated in cells, decreased fertility and pathological disease states can occur. The mechanisms that allow eggs (oocytes) to maintain their quality throughout oogenesis are fundamental, conserved processes; thus, the knowledge gained from this research has implications for understanding infertility and birth defects. The proposed experiments test the hypotheses that the conserved Ras-ERK signaling pathway inhibits the condensation of RNA binding proteins which is necessary for the translational regulation of maternal mRNAs, and that ERK modulates condensation via regulation of the CCT chaperonin and/or remodeling of the ER or cytoskeleton.